Network medicine-based discovery of therapeutics for knee osteoarthritis

ABSTRACT
Knee osteoarthritis (KOA) represents a major public health burden, affecting more than 30 million individuals
in the United States and typically leading to significant declines in physical mobility and compromised quality
of life. Despite its profound impact on our aging population, the standard of care, including exercise and self-
management through diet and nutrition, is currently limited to symptom management and functional
improvement. To address the lack of disease-modifying interventions for KOA, we herein propose to
investigate whether and how different mechanical loading protocols regulate knee joint health when applied in
isolation (Aim 1) or combined with nutritional approaches (Aim 2) by using aged male and menopausal female
murine models of age-related KOA. Specifically, in Aim 1, we aim to mechanistically interrogate how varying
doses of exercise regulate cartilage health in age-related KOA according to sex. In Aim 2, we will determine
whether and how exercise and nutritional approaches exert a synergistic effect in ameliorating age-related
KOA. We will accomplish these aims using technically innovative approaches, including a menopausal murine
model to better recapitulate female aging and an advanced network medicine approach integrated with machine
learning algorithms to elucidate the molecular landscape of the disease-modifying impacts of exercise in
isolation or combined with nutrition. These innovative studies will be carried out by an interdisciplinary team
comprising a rehabilitation clinician and computational biologist (PI), a stem cell biologist (co-I), a bioengineer
(co-I), and a registered dietitian nutritionist and exercise physiologist (consultant). The breadth of this team
enhances feasibility, impact, and the likelihood of success. Successful completion of the proposed aims will
provide mechanistic insights into how rehabilitation programs dictate knee joint health according to sex at both
the symptom and disease levels. Ultimately, we anticipate that the innovative research studies proposed will aid
in the development of exercise mimetics and mechano-active scaffolds designed to selectively induce anabolic
responses in cells, considering sex-specific variables to the benefit our aging population.

Public health relevance
PROJECT NARRATIVE While knee osteoarthritis represents a major public health burden affecting more than 30 million older individuals in the United States alone, the standard of care is primarily limited to symptom management. This study will mechanistically interrogate the effects of different exercise protocols, applied in isolation or in combination with nutritional approaches, on cartilage integrity with aging and according to sex. We anticipate that the innovative research studies proposed will aid in the development of effective rehabilitation programs that consider sex-specific variables for the treatment of osteoarthritis.